NOT-OD-23-070: Empowering Cloud Computing for Non-image-based Diabetic Retinopathy Screening by Designing an EHR-oriented Incremental Learning Framework

Project Summary/Abstract
Despite the high prevalence of diabetic retinopathy (DR), the recommended annual ophthalmic exam for
diabetic patients has a very low compliance rate, only around 43%. Many patients do not seek proper
medical attention because DR is asymptomatic in the early stage, and thus miss the most effective period to
halt DR progression and prevent vision loss. Moreover, ophthalmic equipment for DR exams is predominantly
limited to urban areas, restricting access by patients in rural communities with limited incomes. All of these
create an urgent need to develop innovative approaches that enable early detection of DR.
Our long-term goal is to develop a cost-effective, non-image based, artificial intelligence (AI) tool for primary
care physicians to assess patients’ risk for DR using comorbidity data and routine lab results, which are widely
available. It will help physicians recommend ophthalmic exams and individual screening frequency for at-risk
patients confidently. The aim of our parent NEI project is to improve data quality and prediction accuracy for
DR screening by harnessing tensor information. The parent project demonstrated the feasibility of detecting the
existence of DR with about 92% accuracy. Our approach is promising to increase the compliance rate of the
recommended ophthalmic exams among asymptotic patients, break the barrier to ubiquitous diabetic eye care
in rural communities, and save thousands of people from blindness.
The deep-learning models developed in the parent project were trained with data from Cerner Real-World Data
(CRWD). CRWD is a nation-wide, comprehensive, relational database of real-world, de-identified, HIPAA-
compliant patient data with over 100 million patients and 1.5 billion encounters from diverse care settings.
Starting from 2023, Cerner moved CRWD to Amazon Web Services (AWS) completely. Cerner updates
CRWD every quarter. The updated data brings opportunities to continuously improve the predictive models, but
also the high computational burden to re-train the models with huge amount of data on the cloud.
The technical objective of this supplemental project is to design an innovative sample recycling-assisted
incremental learning (SR-IL) framework to update deep neural network models with newly added EHR data,
without requiring completely re-training the models. We will implement the proposed SR-IL framework on AWS
to continuously improve our predictive models for non-image-based DR screening.
More and more Electronic Health Record (EHR) data are being moved to the cloud today. However, there is no
EHR-oriented incremental learning framework to reduce the computational burden caused by updating
healthcare analytics models on the cloud. The methodology developed from this study will contribute to
increasing the efficiency of healthcare analytics and help continuously improve the performance of the
predictive models of other diseases without adding high computational burden to completely re-train the deep-
learning models with huge amount of data on the cloud.

Public health relevance
Narratives As more and more Electronic Health Record (EHR) data are being moved to the cloud, it brings opportunities to continuously improve the predictive models, but also the high computational burden on the cloud to re- train the deep-learning models with huge amount of data. In this supplemental project, we aim to design an innovative sample recycling-assisted incremental learning (SR-IL) framework to update deep neural network models with newly added data on the cloud, without requiring completely re-training the models. We will implement the proposed SR-IL framework with the Cerner Real-World Data (CRWD) on Amazon Web Services (AWS) to continuously improve data quality and the accuracy of the deep-learning models developed in the parent NEI project for non-image-based diabetic retinopathy screening with routine lab results and comorbidity information.